Digital biomarkers in narrative and conversational speech in Frontotemporal Dementia

Today clinical criteria are the gold standard to identify variants of Frontotemporal Dementia (FTD). Though well
established and useful clinically, these criteria rely on lengthy procedures that are expensive and invasive.
There is urgent need for reliable, objective, and valid measures to screen for likely pathology and monitor
disease longitudinally in disease-modifying treatment trials. While preparing the PI to become an independent
translational researcher, this research program addresses clinical objectives to develop novel, reproducible,
inexpensive, non-invasive, validated biomarkers derived from automated analyses of digitized speech in
patients with Frontotemporal Lobar Degeneration (FTLD) pathology. This program is also designed with the
scientific objectives to enrich neurobiologic models of language with essential but missing speech components
and to improve our pathophysiologic understanding of spreading pathology. In Aim 1 of the K99 mentored
phase, the PI will identify informative digitized acoustic and lexical markers in antemortem speech and relate
these directly to regional pathologic burden in FTLD-Tau and FTLD-TDP, and uniquely study these speech
markers and associated MRI cortical thinning in presymptomatic and symptomatic mutation carriers. In Aim 2,
she will examine acoustic and lexical markers longitudinally in FTLD-Tau and FTLD-TDP and in mutation
carriers. The PI’s preliminary data show that automated algorithms such as automated speech recognition
(ASR) and natural language processing (NLP) tools extract novel digital markers from speech that are
sensitive and specific to FTD phenotypes, are associated with imaging and biofluid markers of underlying
FTLD pathology, and are related directly to regional pathologic burden in cross-sectional and longitudinal
studies of autopsied FTLD-Tau and FTLD-TDP as well as carriers of mutations related to FTLD. During the
R00 independent phase, Aim 3 will discover novel markers in the highly elusive domain of natural
conversational speech, the most common form of human-to-human communication, and relate these to
biomarkers of FTD. The PI will accomplish these aims with the guidance of a world-class mentoring team (Drs.
Murray Grossman, Mark Liberman, James Gee, and David Irwin) who have expertise in computational
linguistics, neuroimaging, and experimental neuropathology. The PI has available a unique database of 1500
digitized speech samples in deeply endophenotyped autopsied cases and mutation carriers. The mentoring
team has a very strong track record of training postdoctoral fellows for independent research careers. A
detailed training plan includes regular one-on-one meetings, seminars, coursework, grant writing, and
responsible conduct of research. The new skills acquired during this period, combined with the PI’s prior
expertise in cognitive neurology and leadership experience as a Major in the military, will ensure a strong
foundation to launch an independent translational research career that will synergistically address vital
scientific and clinical issues.

Public health relevance
This proposal aims to develop novel, inexpensive and reproducible digital speech markers of aphasic and non- aphasic variants of Frontotemporal Dementia (FTD) using automated computational linguistic algorithms, and validate them using quantitative, regional Frontotemporal Lobar Degeneration (FTLD) pathology and carriers of mutations associated with FTLD spectrum pathology. This will advance neurobiologic models of speech and provide validated, longitudinal in vivo models reflecting spreading pathology while synergistically developing in vivo screening measures for specific FTLD pathologies and providing validated longitudinal markers for disease-modifying treatment trials. The research strategies outlined in this proposal will give me the necessary training to advance the study of neurodegeneration and improve the lives of these patients, their caregivers and families while I develop the skill set to become an independent, NIH-funded translational investigator.